Network-targeted theta-burst stimulation for episodic memory improvement in mild cognitive impairment

Project Summary/Abstract
Alzheimer’s Disease (AD) affects millions of people in the US and worldwide, and is becoming an increased
burden on individual and society. Individuals with amnestic mild cognitive impairment (aMCI) are at greater
risk for development of AD. A reliable method of treatment for individuals with aMCI could help not only to
improve the lives of elderly individuals with memory impairment, but also potentially prevent or delay the
development of AD. Theta burst transcranial magnetic stimulation (TBS) is a non-invasive neuromodulation
method that shows promise for improving memory and may be applied to brain areas that are functionally
connected to the hippocampus in order to restore memory function. Because the ability to apply stimulation to
modify memory functions depends on the application of stimulation at distinct and specific sites in the complex
neuronal circuitry underlying these functions, neuroimaging guided targeting of TBS treatment will provide
individualized tailoring of therapeutic intervention needed for maximum efficacy. The proposed project will
therefore implement a novel high-resolution functional magnetic resonance imaging (fMRI) guided TBS method
to improve hippocampal-cortical connectivity and consequent episodic memory in elderly aMCI individuals with
and without genetic risk for AD. Functional MRI, scalp electroencephalography (EEG), and genetic testing will
also be used to characterize brain network changes and genetic factors that are associated with TBS related
memory restoration. The implications of TBS related memory restoration to patients affected with disorders of
memory is of great significance and of urgent need. The proposed project will therefore develop a novel
method for memory enhancement, characterize associated brain changes, contribute to the understanding of
hippocampal-cortical networks and their role in memory, and ultimately provide a novel therapeutic approach to
human memory disorders. The data from this project will demonstrate a proof-of-concept that TBS can be used
to improve memory in aMCI, and will launch an emerging and pivotal area of research that will provide
therapeutic interventions for patients afflicted with life debilitating cognitive disorders.

Public health relevance
Project Narrative Alzheimer’s disease (AD) is the most common form of dementia and affects as many as six million Americans, with incidence increasing with lifespan and healthcare costs astronomical. Because amnestic mild cognitive impairment (aMCI) can often precede conversion to full AD, with accelerated and debilitating memory deficits, it is increasingly important to develop therapies that can restore memory function in aMCI subjects prior to conversion and grant a multipronged understanding of the neural basis for aMCI as a precursor to AD. We will combine structural and functional magnetic resonance imaging, scalp electroencephalography, genetic testing, and image-guided theta-burst transcranial magnetic stimulation to improve memory function in elderly individuals with aMCI and elucidate individual differences and functional changes underlying clinical improvements, aiding the development of individually tailored noninvasive therapies for restoring memory function and contributing to our knowledge of the functional bases of memory in the coherence and dynamic evolution of brain networks.